Analysis Core

ANALYSIS CORE SUMMARY
There is extensive need for development of a skilled workforce for the study of disparities in Alzheimer's
Disease and Related Dementias (ADRD). Due to the aging of the US population, the numbers of persons with
ADRD are increasing. The exponential rise of numbers of people with ADRD is greater among ethnic
minorities, particularly Hispanics and non-Hispanic Blacks, compared with Non-Hispanic Whites. The study of
health disparities related to ADRD requires a transdisciplinary approach that includes research in social
determinants of health (SDOH), behavioral science, mental health, epidemiology, ADRD biomarkers,
neuropsychology, measurement, biostatistics, bioinformatics, clinical trials, and caregiving. The Columbia
Center for Interdisciplinary Research on Alzheimer's Disease Disparities” (CIRAD) Analysis Core (AnC) has
three main goals: 1) assist in the production and application of new measures and methods for studying health,
social and environmental factors, and behavior across the life course among ethnically diverse populations; 2)
provide technical assistance to RCMAR Scientists; and 3) support a mentoring method for pilot investigators
through study grids to be used in the Work-in-Progress (WIP) mentoring seminars, methods internships and
training workshops. CIRAD will work with the other RCMAR AnCs and the Coordinating Center (CC) in: a)
collaborative research projects, b) publications, and c) a website resource that contains measurement reviews
and recommendations for appropriate measures and methods for use in studying ADRD in diverse
populations. The AnC will leverage collaborations with the Alzheimer's Disease Research Centers (ADRC) at
Columbia University Medical Center (CUMC), the Pepper Center at Mt. Sinai School of Medicine and the Weill
Cornell Roybal Center to provide cross-site research and mentoring opportunities for RCMAR Scientists. The
AnC will assist Research Education Component (REC) leaders (Drs. Aiello and Byrd) with applications from
RCMAR Scientists. A focus of methodological development will be related to the primary theme of the CIRAD:
interdisciplinary research on biological, behavioral, sociocultural, and environmental mechanisms of disparities
in ADRD, including risk and resilience factors, biomarkers, and caregiving. The proposed AnC is focused on
measurement but is also examining analytic methods for secondary data analyses involving biomarkers. The
AnC will achieve its goals through the following specific aims: Specific Aims 1 & 2: Methodological and
statistical mentoring of junior investigators; Specific Aims 3 & 4: Measurement: Identifying, cataloging, and
distributing culturally informed measures; Specific Aims 5 & 6: Development of methods and analyses related
to the CIRAD theme of mechanisms of ADRD disparities; Specific Aims 7 & 8: Development of further
collaborative relationships with other RCMAR and NIA Centers.